Biological Discovery through Chemical Innovation Training Program at Emory University

Project Summary
The Biological Discovery through Chemical Innovation training program (BDCI TP) is a new, innovative
predoctoral training program at Emory University, focused on providing specialized training in interdisciplinary
science to students working at the critical intersection of chemistry, biology, and human health, with a particular
emphasis on drug discovery and development. Emory provides a rich environment for this training program, with
demonstrated strengths and depth of knowledge across several disciplines from basic science to translational
research and clinical practice. This program aims to provide trainees with the knowledge, language, and skills
needed to tackle the most pressing challenges in human health and disease, and ultimately prepare them for
diverse careers in the biomedical workforce. To do this, we have carefully designed a training program that
provides specialized, interdisciplinary training to supplement the foundational, discipline-specific training they
will receive in their home graduate programs. Trainees in the BDCI TP will be supported during years 2 and 3 of
their graduate training and will be drawn from several different graduate programs, including Chemistry and a
strategic group of programs in the life sciences within the Graduate Division of Biological and Biomedical
Sciences. With a specific emphasis on driving diversity within the program, the BDCI TP will support 6 students
per cohort, for a total of 12 students per year as the program matures. Designed to provide significant value to
trainees, the BDCI TP includes a new interdisciplinary course focused on therapeutic discovery and
development, a new workshop series aimed at driving cross-disciplinary language development and tailored
ethics and rigor training in the area of interdisciplinary/team science, an annual symposium for trainees to present
their work and network with leaders in the field of chemical biology, an immersive research experience outside
their mentor’s laboratory, a bi-annual retreat with other CBI programs at complementary institutions, and support
for trainees to pursue unique professional development opportunities. Altogether, this program will equip trainees
to succeed in the increasingly interdisciplinary field of modern therapeutic innovation.

Public health relevance
Project Narrative This application requests funding to support a new predoctoral training program at Emory University, focused on providing specialized, interdisciplinary training to students working at the critical intersection of chemistry, biology, and human health, with a particular emphasis on drug discovery and development. Through the construction of a diverse cohort and unique training plan, we aim to equip trainees with the knowledge, creativity, and motivation to solve significant problems in chemical biology, drive therapeutic innovation, and succeed in diverse careers in the biomedical workforce.